The development of humanized SEMA7A-antagonist mAbs for the therapeutic treatment of breast cancer

PROJECT SUMMARY
Breast cancer (BC) is the most commonly diagnosed cancer globally and poses significant risk to postpartum
women. Targeted therapies have emerged as promising treatment for a variety of cancers and offer a less toxic
alternative to traditional treatment strategies, such as chemotherapy. While targeted therapies exist for estrogen
receptor positive (ER+) breast cancers, which account for over 70% of cases, ER+ BC is responsible for the
majority of BC-related deaths, highlighting the need for improved therapeutic strategies. Furthermore, there are
currently no targeted therapies available for the treatment triple-negative breast cancers (TNBC), which are
highly aggressive and rely on toxic treatment strategies. Preliminary research has identified Semaphorin 7a
(SEMA7A) as a factor associated with decreased survival and treatment resistance in both ER+ and TNBC,
leading to increased tumor progression. In response, a novel SEMA7A monoclonal antibody (SmAbH1) was
developed, and demonstrates significant potential for slowing tumor progression and diminishing tumor burden
in preclinical models. Consequently, PearlSci seeks to further develop and harness SEMA7A-antagonist
therapies for BC and potentially other types of cancer. The company's research in this proposal focuses on
identifying and validating humanized SEMA7A-antagonist monoclonal antibodies (mAbs) with high binding
affinity, characterizing their efficacy in blocking SEMA7A-mediated mechanisms and tumor growth, and
assessing their safety and toxicity. Success of the proposed research could lead to more effective treatments for
various forms of breast cancer, which will reduce the overall impact on healthcare systems and improve patient
outcomes.

Public health relevance
PROJECT NARRATIVE Breast cancer (BC) is the most commonly diagnosed form of cancer and poses a significant risk to postpartum women. Currently there are no targeted therapies available to treat triple-negative BC and estrogen receptor negative BC, highlighting the need for complementary strategies to improve the current standard of care.